Project 2: The GABP-TERT axis in immortality of Oligodendroglioma and Glioblastoma

PROJECT SUMMARY/ABSTRACT
The goal of Project 2 is to understand how factors uniquely recruited to the mutant TERT promoter (TERTp)
together with factors that are native to the wildtype (WT) promoter activate TERT to achieve tumor cell
immortality. TERTp mutation occurs in nearly all glioblastoma (GBM) and oligodendroglioma (OD), enabling
tumor cells to become immortal. We showed that the mutations allow the GA-binding protein (GABP) to
aberrantly activate the mutant TERTp across many cancer types. In our preliminary data and new publication,
reduction of GABP in GBM causes decreased TERT and a gradual and nearly complete loss of viability in a
TERTp mutation-dependent manner. GABP is not normally present at the TERTp, however little else is known
about this newly discovered central node in tumor cell immortality. We have discovered two novel candidate
molecules - RNF2, an ubiquitin ligase that appears to drive activation of the mutant TERTp; and the tumor
suppressor CIC that represses WT and mutant TERTp, but is recurrently mutated in OD and downregulated in
GBM. Here, we will test the hypothesis that activation of the mutant TERTp and tumor immortality by GABP
involve critical contributions from mutant allele-specific factors and native factors. In Aim 1, we will define the
role of mutant-specific recruitment of RNF2 in promoting TERT expression and immortality. We will examine
RNF2 recruitment to, and regulation of mutant TERTp across GBM and OD cultures, determine if knockdown
of RNF2 alters telomerase activity, telomere length and tumor cell viability in vitro and tumorigenesis in vivo,
and if combined inhibition of GABP and RNF2 accelerates these processes. Potential resistance mechanisms
in tumors that grow despite reduced GABP will be addressed. In Aim 2, we will determine how WT and mutant
CIC regulates TERT expression and immortality. WT CIC suppresses transcription several ETS factors which
we previously demonstrated normally activate the WT and mutant TERT promoter. We will test CIC
suppression of TERT expression across GBM and OD cultures, then test whether the recurrent loss of function
mutations found in OD upregulate TERT, and which ETS factors mediate the effect. We will knockdown the
CIC-regulated ETS factors and determine if they alter telomerase activity, telomere length and tumor cell
immortality. In Aim 3, we propose to more broadly discover novel regulators of immortality using an in vivo
CRISPRi screen. The gene inhibition will be modeled in TERTp mutant GBM cells with and without GABP-
editing in order to identify factors that regulate cellular immortality in vivo either independently of or
synergistically with GABP. Our results in glioma will build upon the central node of TERT-GABP interaction
which we discovered, and may be relevant to the wider spectrum of TERTp mutant tumor types. By
contrasting mechanisms of TERT regulation in two clinically distinct glioma subtypes -OD and GBM- we will
identify TERTp regulatory mechanisms that are shared, or subtype-specific and potentially linked to the
different patient outcomes. The tumor cell specific regulators may present new therapeutic opportunities.

Public health relevance
Brain tumors and many other tumor types achieve immortality, the ability to proliferate indefinitely, through a mutation in the promoter of the TERT gene, which is the third most common mutation in human cancer. We believe that understanding how the proteins uniquely attracted by the promoter mutation and those proteins that are native to the promoter may be the key to tumor cell immortality. One or more of these proteins may prove to be valuable as a new therapeutic target to reverse tumor immortality specifically in TERT promoter mutant cancer cells, sparing TERT-expressing normal stem cells. This would be a fundmentally different approach than targeting TERT directly, an approach that has failed in clinical trials due to stem cell toxicity. Findings from this project will provide the mechanistic basis for the MRS-detectable, metabolic changes associated with TERT expression, which will be studied in Project 3.